MID-CAREER AWARD IN PATIENT-ORIENTED DRUG ABUSE RESEARCH

PROJECT SUMMARY
Drug abuse and addiction are devastating and chronic conditions that place a significant medical, financial, legal
and social burden on our country. Interdisciplinary collaboration combined with technical advances has resulted
in unprecedented opportunities to enhance addiction treatment efficacy and durability, and reduce vulnerability
to addiction. Continued progress is vital to improving existing evidenced-based treatments and developing new
treatments. It is therefore critical to attract and train clinical researchers in order to ensure that a diverse pool of
highly skilled scientists will be available to address these urgent health care needs. Dr. Aimee McRae-Clark is a
productive mid-career investigator who has maintained consistent NIH funding for her innovative work in the
area of medications development and gender differences in addictions. In addition, she has a strong track-record
of attracting and successfully mentoring medical, graduate and post-doctoral students as well as junior faculty
in clinical research focused on substance use disorders, as evidenced by the accomplishments of her previous
K24 award. The objective of this Midcareer Investigator Award in Patient-Oriented Research renewal application
is to provide support for protected time so that Dr. McRae-Clark can expand her formal, intensive program of
mentored clinical research training and career development activities to promote junior scholars in the area of
drug abuse and addiction. As in her initial award, particular emphasis will also be placed on increasing the
participation of underrepresented minorities, women, and other diverse individuals conducting patient-oriented
research. In addition, she will build on her existing program of research by incorporating new proficiencies and
research directions, including obtaining further didactic and experiential training in mentorship and leadership
skill development; participating in opioid treatment-related initiatives and research; and expanding her work to
improve clinical trial remote monitoring technology.

Public health relevance
PROJECT NARRATIVE Intensive, mentored clinical training focused on drug abuse and addiction helps ensure that there is a diverse pool of highly trained scientists available to improve treatment outcomes. The objective of this Midcareer Investigator Award in Patient-Oriented Research renewal application is to provide support for protected time so that Dr. Aimee McRae-Clark can continue her formal, intensive program of mentored clinical research training and career development activities to promote junior scholars in the area of drug abuse and addiction.